Integrated Networks of Scholars in Global Health Research Training (INSIGHT) Program

PROJECT ABSTRACT
This project abstract presents the Integrated Networks of Scholars in Global Health Research Training (INSIGHT) Program. We have faculty members across our multidisciplinary and multi-institutional consortium working with institutions in the U.S., sub-Saharan Africa, South Asia, Latin America, and the Caribbean. The program’s strategic focus is on a broad range of global health research areas, including combatting the global HIV epidemic and associated co-morbidities, emerging and re-emerging infectious diseases, childhood chronic diseases, and non-communicable diseases.
A vision statement encompassing five Themes – Global Impact, Multidisciplinary Science, Integrated Training for All, Next Generation of U.S. Health Researchers and a Highly Committed Environment– shape our work. Key innovations strengthening this proposal include leveraging our institutional commitments in global research training, amalgamating our strong clinical, behavioral, and laboratory science foundations, enacting a participatory monitoring and evaluation program, and launching emerging leaders.

Public health relevance
Public Health Relevance - Investing in global health research training is a strategic move to advance U.S. leadership in global science, security, and innovation. We bolster our national health, economy, and influence by equipping American and LMIC professionals to collaborate internationally and address shared challenges. Training in global health research is not just an investment in education—it's a powerful tool for understanding and finding solutions to lower chronic disease rates, improving health outcomes, and making America greater, safer, and more competitive. Aim 1 – Create collaborative, robust global health research that collaborates across institutional pairing of mentors. The research training "triad" of U.S. mentors, LMIC mentors, and scholars form a long-term training partnership that builds research capacity for all scholars and partner institutions. Outcomes: Robust interdisciplinary collaboration generating innovative research driven by integration and partnership between our four universities and LMIC partners. Aim 2 – Provide one-year research training for 105 scholars with linkage to the Mentorship Triad Paradigm. We will provide training for five yearly cohorts of 15 scholars in global health research, including coursework and a mentored research practicum. We will leverage an institutional commitment of $1.5 million to support an additional 30 scholars over five years to maximize impact. Outcomes: 90% of scholars completing training will submit grant proposals and/or publish their research. Aim 3 – Support scholars' transition into successful and sustainable research careers. We will link scholar selection to research programs that align with NIH research priorities. Outcomes: Sustained collaboration between scholars and INSIGHT consortium researchers for at least